Cancer Research Training and Education Coordination

CANCER RESEARCH TRAINING AND EDUCATION COORDINATION (CRTEC) – ABSTRACT
Karmanos Cancer Institute (KCI) provides extensive cancer research training and educational programs that span all career stages. Dr. Michele Cote (PSDR), Associate Center Director for Education, leads KCI’s CRTEC efforts. In addition to identification, promotion, and support of University-sponsored training activities, Dr. Cote (PSDR) coordinates the cancer-specific programs at KCI. With the support of CRTEC Education Advisory Council members, each with expertise in a particular field or window of training, Dr. Cote (PSDR) serves as the main point of contact for trainees across the career trajectory. A key component of the CRTEC is to evaluate the effectiveness of the supported training activities, and identifying gaps and opportunities to enhance KCI training efforts across the spectrum.

KCI’s education efforts span the education and training continuum including efforts focused on high school students, undergraduate students, graduate and medical students, post-doctoral trainees, residents and fellows, junior faculty, tenured faculty and community healthcare providers. CRTEC efforts are supported by ten active training projects totaling $895,210 direct costs. Several have grown out of a T32 led by Dr. Matherly (MT) (T32CA009531). This training program in the biology of cancer that has been continuously funded for over three decades. Since 2015, 24 students have been supported via the T32, five of whom were also awarded subsequent F30 or F31 support. Novel efforts at KCI include the launch of focuSStem in 2019, a program developed by a high school student, for high school students, with support from KCI leadership. In its inaugural year, five schools and 149 students have participated in the day-long program. A recent addition to our efforts in reaching high school students is the Discovery to Cure High School Internship Program (DTCHIP) (R25HD072591) led by Dr. Gil Mor (TBM) which will begin recruiting in the summer of 2020.